Uncovering novel mechanisms of the CELF/Bruno protein ETR-1 in apoptosis

PROJECT SUMMARY/ABSTRACT:
Programmed cell death or apoptosis is a natural developmental process. Failure of apoptosis can lead to
developmental abnormalities, cancer (uncontrolled growth) and autoimmune diseases, while excessive
apoptosis contributes to neurodegenerative diseases like Alzheimer's and Parkinson's. New players in the
various stages of apoptosis (initiation, execution, and engulfment) continue to be identified, indicating that our
understanding of the mechanism by which apoptosis occurs and is regulated is still lacking. C. elegans is an
ideally suited genetic system to address apoptotic research questions because the transparent animals allows
real time, in vivo, observation of apoptosis in the germline (physiological or stress-induced germline apoptosis).
We recently identified a well-conserved RNA-binding protein (RBP) in C. elegans belonging to the highly
conserved CELF/Bruno protein family, ETR-1, as playing a role in germline apoptosis. Preliminary findings
show that depletion of ETR-1 results in accumulation of germline apoptotic cells and that a member of the
apoptotic engulfment pathway is a potential mRNA target of ETR-1. The overall objective of this proposed
study is to elucidate ETR-1's function during germline apoptosis, and the mechanism by which ETR-1 acts
during apoptosis. The central hypothesis guiding the proposed work is that ETR-1 functions in a RNA-binding
dependent manner during the early stages of physiological germline apoptosis to regulate execution and also
in the later stage of engulfment. The rationale for this research is that successful completion will contribute to
our fundamental understanding of apoptosis at multiple levels. To test the central hypothesis, we have devised
two specific aims. Specific Aim 1 will focus on determining the role of ETR-1 in either physiological or stress-
induced apoptosis through examining the kinetics of apoptosis upon ETR-1 depletion and the tissue specific
requirement of ETR-1 in the gonad as related to apoptosis. Specific Aim 2 will focus on understanding the
function of the RNA Recognition Motif (RRM) domains of ETR-1 during germline apoptosis. The proposed work
is innovative because we will be elucidating in vivo the role for a novel apoptotic player in an intact multicellular
organism, and identifying mRNA targets for a previously uncharacterized RNA-binding protein. Completion of
these aims will provide a more thorough understanding of the process of apoptosis, and how apoptosis is
properly controlled. Another important long-term goal of this proposal is to foster undergraduate student
interest in the area of biomedical research. This proposal will facilitate substantial participation of
underrepresented minority students in their early career years at Howard University, a major HBCU
(Historically Black Colleges and Universities). This research has strong

Public health relevance
PROJECT NARRATIVE: Our research has strong public health relevance as it will contribute new insights into the basic mechanism of programmed cell death or apoptosis. Expanding our knowledge of the role that RNA-binding proteins (RBPs) play during apoptosis directly influences the human health field. Additionally, increased mechanistic knowledge of RBP function contributes to studies of numerous diseases associated with abnormal gene expression, such as cancer and muscular dystrophy. Thus the proposed research is relevant to the NIH's overarching mission to help reduce the burden to society that illnesses and diseases play.